Novel Nutrient Functions and Sensing Mechanisms

Project Summary
In our original proposal for the R35 grant application, we described the two major goals of the research
in the field of nutrient function and sensing. One is to discover nutrient value, or the benefits, of specific
bacteria-produced metabolites on human physiology, which had been predicted by the symbiotic
relationship between commensal microbes and host animals. The second goal was to uncover novel
mechanisms that regulate specific physiological events in response to deficiency of specific nutrients that
include fatty acids, nucleotides, and amino acids. These studies address fundamental questions that are
closely related to human health. For this "Supplement Application" that aims to acquire funding for
purchasing a piece of equipment to measure oxidative respiration in animal cells, the research strategy
mainly focuses on the first goal. Using innovative genetic screens in the nematode C. elegans, we have
identified unexpected beneficial roles of certain bacterial metabolites, including the siderophore enterobactin
and bacterial cell wall components peptidoglycan muropeptides, on animal development and behaviors.
Supported by the R35 grant and its R01 precursor grant, we have made exciting progress in understanding
the mechanisms underlying these novel functions. Both molecules enter the mitochondria of host intestinal
cells, bind to ATP synthase, and promote basic mitochondrial functions. In the case of muropeptides, we
have found that beneficial molecules are disaccharide muropeptides containing a short AA chain, and they
enter mitochondria of intestinal cells to repress oxidative stress. Strikingly, muropeptides execute this role
by binding to multiple subunits of ATP synthase, which consequently stabilizes the complex and promotes
its activity. This finding defined the first agonist of the ATP synthase. More recent studies using cultured
human intestinal epithelial cells, fibroblasts from a disease patient, and mice treated with antibiotics have
clearly indicated the roles of muropeptides in promoting oxidative phosphorylation and suppressing
oxidative stress in mammalian cells. In the next several years, we will continue to expand the analyses on
potent muropeptides to understand its structural property, its role in promoting oxidative phosphorylation in
different mammalian tissues, and its potential effect in suppressing mitochondrial dysfunction in disease
cells and mice. Such studies are of high medical significance, as mitochondrial dysfunction is well known to
be associated with a broad range of human diseases including major neurodegenerative, cardiovascular,
and metabolic diseases. We also plan to explore potential roles of other metabolites and nutrient sensing
mechanisms in mitochondrial homeostasis. Having a Seahorse Analyzer to examine oxidative respiration
would greatly facilitate these proposed studies on mitochondrial functions.

Public health relevance
Project Narrative The proposed study will explore the roles of peptidoglycan muropeptides in promoting oxidative phosphorylation and suppressing oxidative stress in mitochondria of animal cells. The structural detail of potential muropeptide, its function as an agonist of ATP synthase, and its effect in different cell types including cells with mitochondrial dysfunction, will be explored. The ability to measure oxidative respiration in cells will produce key data for the proposed studies.